Developing a cell-on-chip platform to study oligodendrocyte-neuron interactions in plasticity and neurodegeneration

PROJECT SUMMARY/ABSTRACT
Myelin sheaths accelerate action potential conduction along axons, conferring myelin the ability to tune action
potential timing and circuit function. Generating new myelin is necessary for learning and memory formation, a
process known as activity-dependent myelination. Despite its capacity for renewal, myelin gradually reduces
with age, which is exacerbated by neurodegenerative disorders including Alzheimer’s disease (AD). Loss of
myelin may directly contribute to age-related cognitive decline, given the evidence that enhancing myelination
in preclinical mouse models of aging and AD improves memory and cognition. How does neuronal activity
regulate myelin sheath formation, and how are these dynamics altered in neurodegeneration? Thus far, current
studies on activity-dependent myelination have been limited to a handful of neuronal cell types and few
stimulation paradigms using optogenetics or patch-clamp electrophysiology. These findings converge on the
general principle that active axons get myelinated. However, fundamental questions remain on how
myelination patterns—through variations in sheath length and number along axons—coordinate network
synchrony and promote circuit function in higher-order brain processes such as learning and memory
formation. Importantly, how myelination patterns may be altered in the context of neurodegeneration remains
unclear. We propose to develop a modular system to study activity-dependent myelination on a high-density
multielectrode array chip using oligodendrocyte-neuron co-cultures that enable i) fine-tuning of neuronal
stimulation, ii) recording of extracellular activity, and iii) imaging of myelin morphology with cellular resolution.
Developing this system will allow us to determine how evoked neuronal activity modulates axon ensheathment,
sheath length, and/or sheath number (Aim 1). This programmable, spatiotemporal control of evoked activity will
unlock the means to systematically vary the timing and amplitude of voltage stimulation and elucidate neuronal
activity patterns that enhance or inhibit myelination. Moreover, this system will also be adapted to study human
induced pluripotent stem cell-derived neuron and oligodendrocyte co-cultures to enable us to determine how
neuronal activity and myelination are altered in models of neurodegenerative disease (Aim 2). We will share
the recorded neuronal activity and corresponding myelin-axon maps on MEA chips on publicly accessible
repositories, providing an open-access resource for pinpointing temporal and activity-dependent parameters to
study myelination of different neuronal cell types and in the context of neurodegeneration. Together, our
proposed studies will establish a modular platform to ask how activity-dependent myelination affects different
neuronal circuits, revealing insight into selective vulnerabilities in neurodegeneration as well as overarching
principles in neuroplasticity.

Public health relevance
PROJECT NARRATIVE Myelin is an emerging contributor of neuroplasticity, which declines in aging and neurodegeneration. Neuronal activity has been shown to remodel and generate new myelin in a process known as activity-dependent myelination, but current studies are limited to a few neuron types, have not examined consequences on circuit synchrony, and have not investigated benefits or consequences of activity-dependent myelination toward neurodegeneration. state-of-the-art multielectrode array system that will enable us to investigate how tuning neuronal activity sculpts myelin formation as well as how myelin, in turn, modulates the spiking activity and network synchrony of control and disease-modeling neurons. We propose to develop a modular platform to study activity-dependent myelination using a